CE21-005 - CDC Youth Violence Prevention Center- Kansas City (YVPC- KC): Evaluation of a Comprehensive Approach to Address Youth Violence

Project Abstract Summary
Youth violence is a critical public health concern. In 2019, there were 46.9 homicides per 100,000 for
youth ages 10 to 24 in the Kansas City (KC) metro area compared to 7.82 in the U.S. overall. Youth homicide
is the third leading cause of death for individuals 15 to 24 years nationally (National Center for Injury
Prevention, 2021), and the leading cause of death for youth in this age group in the KC metro area. Youth
violence disproportionately affects racial and ethnic youth. Black and Hispanic/Latinx youth experience greater
disparities in youth violence nationally and in the Kansas City (KC) metro area. In 2019, 71% of the 57 youth
homicides in the KC metro area involved Black or Hispanic/Latinx youth ages 10 to 24.
The goal of the proposed KC Youth Violence Prevention Center is to examine implementation of
ThrYve (Together Helping Reduce Youth Violence) as a multicomponent approach to prevent youth violence
(i.e., youth homicides) and reduce associated risks (e.g., intentional injury hospital admission), particularly
among Black and Latinx youth. The geographic focus is the KC metro area, including both KC, KS & KC, MO
neighborhoods with high rates of youth violence. The ThrYve model examines the implementation of two
prevention strategies including: (a) ThrYve4Change, a youth mobilization strategy and (b) REVIVE, a scaled
multisite hospital violence prevention program. The rationale is that testing the ThrYve model using a more
rigorous approach across multiple neighborhoods (i.e., school catchment areas) with elevated rates of youth
violence and high hospitalization rates will expand the evidence base for the effectiveness and generalizability
of participatory strategies to prevent and reduce youth violence. The study will use interrupted time series and
multiple baseline designs across three neighborhoods (i.e., school catchment areas) in the KC metro area.
Additionally, a multisite hospital violence prevention program will be evaluated across four local hospital sites.
The following aims will be examined in the study to understand the impact of the comprehensive
prevention strategies on community outcomes and related factors: Specific Aim 1: Evaluate the effectiveness
of the multi-component ThrYve Model, including ThrYve4Change (youth mobilization strategy) & REVIVE
(Reducing the Effects of Violence through Intervention and Victim Empowerment) (multisite hospital violence
prevention program) on changes in community conditions (i.e., prevention practices, programs, &
policies) and youth homicide rates. Specific Aim 2: Examine the impact of the ThrYve4Change youth
mobilization strategy on associated risks & protective factors (e.g., academic performance) for youth in three
neighborhoods (i.e., school catchment areas). Specific Aim 3: Evaluate the effectiveness of implementing a
scaled hospital violence prevention program on firearm-related hospital admissions and readmissions of youth
participants.

Public health relevance
Project Narrative Youth violence is a critical public health concern disproportionately affecting racial and ethnic youth. Comprehensive youth violence prevention strategies can improve community outcomes.